Data Science Core

P20 Data Science Core

Modified Project Summary/Abstract Section

PROJECT SUMMARY/ABSTRACT – Data Science
Vermont Biomedical Research Network Data Science Core (VBRN DSC) provides a full range of informatics services needed for biomedical research throughout the State of Vermont, including consultation for experimental design; comprehensive data analysis; support for data management; and education and training in data science for faculty and undergraduate students. Core personnel use nextflow-core standardized, containerized pipelines as well as custom pipelines for specialized faculty projects. We provide all users custom reports and text for publications and grant proposals, along with assistance in data deposition into public databases to optimize reuse of data from the core. We leverage the Vermont Advanced Computing Center (VACC) at the lead institution for high performance compute (HPC) and data storage as well as cloud-based resources for work on collaborative projects and education and training across the network.
The Data Science Core goals for INBRE 5 will continue supporting data science research and broadening data science education for faculty and student researchers in the network, with an emphasis at PUIs, using multiple approaches. These will consist of (i) expanding data science services to include multi-omics projects, (ii) support data science training and education for VBRN network investigators and their students, (iii) expand access to computational services, and (iv) strengthen biomedical resources sharing across the network. Our specific aims include: 1) to continue to provide high quality and comprehensive data science services; 2) to enhance biomedical resources sharing, including through our partnerships with collaborative groups and resources at UVM and institutions across the network; 3) to support data science training and education for VBRN network investigators and their students; and 4) to provide access to IT and computational services and hardware for VBRN Core Facilities and investigators.